Aurora NCORP Community Site

PROJECT SUMMARY
The Aurora NCORP community site is building upon the recent merger of two high-quality health systems to
increase our capacity to enroll patients in a variety of NCI-sponsored clinical trials. Advocate Aurora Health
serves approximately 16,500 newly diagnosed adult and pediatric cancer patients annually throughout
Wisconsin and Illinois. Specifically, the Aurora NCORP will:
• Increase accrual to NCI-sponsored clinical trials in adult and pediatric research.
• Expand our trial portfolio to reflect the depth and breadth of NCI-sponsored clinical trials.
• Conduct cancer care delivery research that utilizes the expansive resources and expertise available
throughout Advocate Aurora Health.
Ultimately, the Aurora NCORP will be able to involve more patients in clinical research that will lead to
improved patient outcomes and a reduction in cancer disparities.

Public health relevance
PROJECT NARRATIVE The Aurora NCORP community site will enroll patients in an expanded portfolio of NCI-sponsored clinical trials. The program is built on a foundation of high-quality cancer care, an experienced leadership structure and a strong clinical research infrastructure.